Neurogranin and Traumatic Brain Injury

Deployed and nondeployed military personnel are at higher risk of traumatic brain injury (TBI) than
civilians. TBI of all severities can result in chronic disturbances of cognitive, behavioral, emotional, and physical
functioning. Learning, memory and attention are especially vulnerable across the spectrum of TBI injury severity
and symptoms may persist years to decades. While most TBIs experienced by Veteran’s are mild, enduring a
severe TBI produces significant personal, societal and economic burden. TBIs that require hospitalization
account for approximately 90% of total TBI medical costs. There are currently no FDA-approved
pharmacotherapies to treat TBI. Thus, research to develop new pharmacotherapies for TBI will benefit Veterans
with persistent posttraumatic neurocognitive disabilities. These impairments have been recapitulated in pre-
clinical TBI models. Animals demonstrate poor performance on cognitive tasks along with associated
pathological synaptic communication on molecular, anatomical and electrophysiological scales. Furthermore,
these models for the investigation of underlying cellular mechanisms and potential therapeutic targets of TBI
associated impairments.
Synaptic strength and plasticity are believed to underlie learning and memory behaviors. Dysfunction of
synapses is one of the earliest and most common abnormalities preceding neuronal death in neurodegenerative
diseases and has been reported in several animal models of TBI. Neurogranin (Ng), a post-synaptic protein
localized to post-synaptic dendritic spines, notably regulates synaptic plasticity through calcium-dependent
temporal and spatial regulation of calmodulin (CaM). Synaptic activity leads to precisely timed changes in Ng
phosphorylation by protein kinase C (PKC). This is synchronized with Ca2+-CaM downstream signaling and
Calcium-Calmodulin Kinase II (CaMKII) activation via autophosphorylation. Ng modulates synaptic excitability
through these pathways. CSF and blood levels of Ng have also been used as biofluid biomarkers of synaptic
neurodegeneration in Alzheimer’s disease and other neurodegenerative syndromes, as well as in acute TBI.
Recently, chronic decreases in plasma exosome levels of Ng was seen in combat-deployment-related mild TBI.
Our recent findings showed significantly reduced Ng protein expression in the rat cortex and hippocampus up to
two weeks after controlled cortical impact, particularly in the CA1 and CA3 of the hippocampus. This evidence
suggests Ng’s potential involvement in pathological mechanisms of learning and memory difficulties after TBI.
The overall hypothesis is that decreased Ng expression contributes to dysfunctional synaptic plasticity
and cognition after TBI. Specific Aim 1 will examine the effects of TBI on Ng signaling, associated synaptic
proteins and dendritic morphology. Preliminary data shows Ng is detectable in serum in sham and CCI-injured
animals at two weeks post-injury. Thus, for the first time, an experimental model can be utilized to directly study
the relationship between biofluid Ng levels and conformational synaptic neuropathology. Specific Aim 2 will next
examine using adeno-associated viral (AAV) delivery to increase neuronal Ng in the hippocampus. Retinoic acid
(RA), a metabolite of Vitamin A, increases Ng protein levels and has been identified as a potential
pharmacotherapeutic for ischemic injury and other neurological disorders. Specific Aim 3 will determine the
effects of RA therapy on Ng signaling, synaptic neurodegeneration, and cognitive function after TBI. Successful
completion of this study will identify Ng as a therapeutic target and biomarker of synaptic dysfunction in TBI.

Public health relevance
Traumatic brain injury (TBI) is a complex neurological condition, and there are currently no FDA-approved treatments to directly treat cognitive deficits. The proposed study will delineate a mechanistic role of Neurogranin (Ng) in the pathophysiology of experimental TBI and use systemic delivery of retinoic acid and adeno-associated viral (AAV) vector-mediated overexpression to elucidate the therapeutic impact of increased Ng expression on restoring synaptic plasticity and functional outcomes after TBI. Successful completion of this study will further our understanding of molecular mechanisms of cognitive dysfunction after TBI.